APOC3 mediated dyslipidemia in diabetic kidney disease and atherosclerosis

A. SUMMARY OR ABSTRACT OF THE FUNDED PARENT GRANT OR PROJECT
People with diabetes are more likely to have cardiovascular disease (CVD) and kidney disease. Most of the
excess risk of CVD in diabetes is restricted to patients with diabetes and diabetic kidney disease (DKD). New
data indicates that apolipoprotein C3 (APOC3) plays a critical role in diabetic atherosclerosis and preliminary
data suggests that it is causally linked to DKD. APOC3 is a key regulator of triglyceride-rich lipoprotein (TRL)
metabolism. It is in turn regulated by insulin, but also by kidney disease. Our overall hypothesis is that diabetes
and kidney disease raise APOC3 levels. Increased levels of TRLs and their remnants, driven by APOC3,
accelerate diabetic kidney disease as well as atherosclerosis. This hypothesis will be tested in 2 separate
aims: Aim 1: Does blocking APOC3 prevent diabetic kidney disease? This will be tested in 2 different
mouse models of diabetes and kidney disease using 2 different approaches to target APOC3; a specific
antisense (ASO) to APOC3 and a transcription factor (CREBH) that has profound effects selectively on TRL-
associated APOC3. Aim 2: Does renal impairment and diabetes act synergistically to elevate APOC3,
contributing atherosclerosis? To test the hypothesis that diabetes and reduced renal function act
synergistically to elevate plasma APOC3 to accelerate atherosclerosis we will induce renal impairment in non-
diabetic and diabetic mice using 5/6 nephrectomy. APOC3 levels will be reduced in these mice using both
APOC3 ASO treatment and hepatic overexpression of CREBH to test the causal role of APOC3. The majority
of the excessive CVD risk in diabetes is present in patients who also have DKD. With the diabetic population
growing, finding new therapeutic targets is exceedingly important. We propose a novel common mechanism
whereby DKD and CVD are accelerated by APOC3-mediated increases in TRLs and their remnants, and a
new way that both can be prevented by blocking APOC3. These studies are likely to reveal important
similarities in the mechanisms whereby APOC3 promotes two of the major complications of diabetes. A human
APOC3 ASO has already been tested in T2DM patients with promising TRL-lowering results, thus APOC3
might be a therapeutic target for combating the rising epidemic of diabetic complications.

Public health relevance
NARRATIVE OF THE FUNDED PARENT GRANT OR PROJECT Diabetes is affecting almost 10% of the adult US population. Diabetes dramatically increases the risk of life- threatening complications such as kidney disease and cardiovascular disease. Here we propose a new way to treat both of these complications.